ANTI-TNFCA2 IN THE TREATMENT OF PATIENTS WITH CROHN'S DISEASE

To evalute the safety and efficacy of chimeric monoclonal anti-TNF antibody (cA2) compared with placebo in closure of enterocutaneous fistulae in patients with Crohn's disease.